Rare and Recalcitrant Cancers for Establishing the Predictive Power of Patient-Derived Xenografts (PDXs)

Rare and Recalcitrant Cancers for Establishing the Predictive Power of Patient-Derived Xenografts (PDXs)